Administrative Core

SUMMARY
The Administrative Core will coordinate the CAMPP AViDD Center by 1) establishing an organizational
structure centered on an Executive Committee responsible for – along with Director, Deputy Directors,
and Scientific Advisory Board (SAB) – monitoring overall program progress and making decisions on
staffing plans, allocation of resources, core usage, and other policies; 2) coordinating regularly held
conference calls between the Center’s research teams and organizing annual meetings between the
PIs, selected key personnel, the SAB and NIAID, as well as annual reverse site visits at NIAID; 3)
assisting the investigators of this consortium in reagent and data sharing, manuscript preparations, IND
preparations, the timely public dissemination of data, and the submission of annual progress reports to
NIAID; and 4) providing support to early career research scientists and established investigators in
other fields to develop independent research skills in antiviral drug research and development by
implementing Developmental Research Projects and Mentored Project Programs. The Core Director
has significant expertise in the coordination of program projects and large-scale multi-institutional
consortia. He served as Director of the HINT consortium, a program project consisting of over 13 PIs
at 10 institutions focusing on systems-based analysis of immune responses to HIV (P01 AI090935),
and as Deputy Director of additional multi-institutional consortia; Fluomics (U19 AI106754) and
Fluomics: The Next Generation (U19 AI135972), which focus on the use of systems-level technologies
to identify host determinants of viral pathogenesis, both for influenza and SARS-CoV-2. More recently,
he was named the PD/PI on a multi-PD/PI NIAID Vaccine Adjuvant Discovery Program contract
(75N93019C00046), the PD/PI on the multi-PD/PI NIAID Reversing Immune Dysfunction for HIV-1
Eradication Program (UM1 AI164561), and the PD of the DoD program Development and Advancement
of Broad-Spectrum Respiratory Antivirals (DABRA) (W81XWH-20-1-0270). Core Deputy Director Dr.
García-Sastre has been the PD of the two Fluomics programs as well as the DABRA program
mentioned above and is thus very well suited to assist Dr. Chanda in successfully leading this multi-
disciplinary program. Deputy Director García-Sastre will oversee the Mentored Project to be initiated in
year 2, supported by his experience in organizing the highly successful Fluomics program for junior
level investigators (EMBED). Deputy Director Dr. Arnab Chatterjee will take responsibility for oversight
of the Developmental Research program and has substantial experience relevant to the development
and advancement of specific antivirals and related basic science studies, having advanced multiple
drug candidates to major technology development licensing deals with Bristol-Myers Squibb, AbbVie,
and Gilead as well as clinical trials.